Novel TNF Secretion Assays

PROJECT SUMMARY
Tumor necrosis factor (TNF or TNFa) is produced and secreted by a variety of eukaryotic cells [e.g.,
macrophages, T cells, mast cells (MCs), epithelial cells, etc.] to regulate a broad spectrum of biological
processes. Excessive TNF, on the other hand, gives rise to allergic inflammation, septic shock, autoimmune
diseases and chronic pain. Synthesized as a type II membrane protein, the full-length, membrane-bound TNF
(mTNF) utilizes conventional secretory carriers to reach the cell surface, where the soluble form (sTNF) is
released into the extracellular space upon Adam17-mediated proteolytic cleavage. It is widely accepted that
the trimeric sTNF mediates local/long distance signaling whereas any mTNF trimers remaining at the cell
surface are responsible for contact-dependent signaling. However, evidence from our lab and others’ suggests
that mTNF can be delivered to MVBs (multivesicular bodies) and released in association with exosomes
(nanovesicles originated from within MVBs) when MVBs fuse with the plasma membrane. This implies that
mTNF is also capable of local/long distance signaling. Notably, sTNF and mTNF have distinct preferences for
different TNF receptors and can trigger distinct pathophysiological responses. For example, while mTNF
seems subservient to sTNF in autoimmune inflammation, it is mTNF, not sTNF, that acts as the major culprit in
colitis or lung inflammation in animal models. Therefore, it has become essential to dissect the two modes of
TNF release to develop more specific and effective interventions to expand and evolve the current collection of
TNF-modulating therapeutics. The objective of this proposal is to build a set of sensitive assays to distinguish
sTNF release from mTNF release, and to help researchers delineate the regulatory and/or catalytic
mechanisms underlying TNF secretion. By tagging a fluorescent protein at the N-terminus (cytoplasmic side) of
TNF in RBL-2H3 MCs, we have generated preliminary data that exosomal mTNF release could be assessed
via the fluorescent signal in the supernatant of culture cells. Meanwhile, there is evidence that a dominant
negative TNF variant (DN-TNF) can intercalate into sTNF trimers but not mTNF trimers. Based on these
observations, we hypothesize that a set of novel assays can be developed/established to differentiate and
dissect the two modes of TNF secretion. To test the hypothesis, we will pursue two specific aims. Aim1 will
establish a fluorescence-based assay to exclusively measure mTNF release. Aim2 will develop a FRET-based
assay to exclusively measure sTNF release. We expect to use these assays to demonstrate that mTNF
release is conserved in TNF producing cells and that the two modes of TNF release can be differentially
regulated by different types of pathophysiological stress.

Public health relevance
PROJECT NARRATIVE Mast cells produce tumor necrosis factor (TNF), a multifunctional cytokine with profound physiological and pathological impact. In this proposal, we develop/establish two novel and convenient assays for researchers to distinguish and dissect the release of two forms of TNF (the soluble form vs the membrane-bound form) that have exhibited distinct biochemical and signaling properties.